Novel determinants of fibrinogen pro-repair activity in acetaminophen-induced liver toxicity

PROJECT SUMMARY
The leading cause of acute liver injury and acute liver failure in the United States is hepatotoxicity caused by
overdose of the pain medication acetaminophen (APAP). Nearly 50% of patients presenting with APAP-
induced liver injury require costly hospitalization, and the efficacy of available treatments (i.e., N-
acetylcysteine) is very limited for patients presenting well after APAP overdose. APAP overdose patients would
benefit most from treatments that maximize liver repair pathways, such as proe-pr air macrophage activation.
We recently discovered a remarkable pathway of liver repair following APAP hepatotoxicity whereby the
clotting protein fibrin(ogen), deposited in the injured liver of both humans and mice, engages β2 integrins and
directs local pro-repair macrophage activity. The fibrin(ogen)-β2 integrin interaction is carefully regulated and
acquired by modifications of fibrin(ogen) structure. Defining the mechanisms whereby fibrin(ogen) is converted
to a β2 integrin ligand that elicits pro-repair macrophage activity in liver injury is critical, as this could uncover
novel putative therapeutic targets to improve liver repair pathways in patients with severe hepatotoxicity or
acute liver failure. Our strong preliminary studies suggest that, in contrast to the current paradigm, hepatic
fibrin(ogen) accumulation caused by acute toxicity is independent of blood coagulation activity. The central
hypothesis framing these studies is that liver injury stimulates coagulation-independent cross-linking of
fibrin(ogen) by tissue transglutaminase-2 (TGM2) to form a novel fibrin(ogen) complex that drives macrophage-
mediated liver repair. Our approach includes genetically-modified mice lacking specific fibrin(ogen) cross-
linking enzymes, mice expressing fibrin(ogen) proteins with specific functional mutations, application of a
coagulation-insensitive fibrin(ogen) as a putative pro-repair therapeutic, a unique cell culture system to
examine primary macrophage activation by unique molecular forms of fibrin(ogen), and analysis of fibrin(ogen)
deposits in livers of human patients with acute liver failure. The investigative team comprises experts in toxic
liver injury and repair, coagulation and fibrin(ogen) biochemistry/function, and mouse modeling of liver disease.
In our proposed studies we will: (Aim 1) Identify the mechanism whereby APAP-induced liver injury stimulates
hepatic deposition of repair-promoting cross-linked fibrin(ogen); (Aim 2) Determine the role of fibrin(ogen)
hemostatic function in repair of the APAP-injured liver; and (Aim 3) Determine the mechanism whereby
fibrin(ogen) cross-linking drives pro-repair macrophage activity in vitro. The expected outcome of these Specific
Aims is discovery of entirely novel mechanisms linking unique structural modification of the clotting protein
fibrin(ogen) with macrophage-mediated liver repair. Identifying these mechanisms could pinpoint putative
targets (e.g., TGM2, β2 integrin-fibrin(ogen) interaction), and novel agents, such as fibrinogen tailored to be
pro-repair and free of thrombotic risk. Indeed, such major advances would provide entirely novel specific
therapies to improve liver repair that would greatly improve patient outcomes.

Public health relevance
PROJECT NARRATIVE Overdose of the commonly used analgesic drug acetaminophen is a leading cause of liver toxicity and liver failure, in part because there have been no major advances in specifc treatments to improve repair of the liver after acute injury. Acute liver injury is associated with deposition of the blood clotting protein fibrinogen in the liver, and our prior studies indicate that fibrinogen stimulates liver repair. The primary goal of this research program is to uncover how changes in fibrinogen structure contribute to its ability to repair the damaged liver, such that new therapies can be designed to promote liver repair in patients with liver toxicity.